Use of radioprotector in rectal cancer

PROJECT SUMMARY
The majority of patients diagnosed with rectal cancer will receive radiation therapy to treat their tumors. Long-
term complications from radiation therapy directed to the colorectal region are bowel fibrosis, rectal wall damage,
bowel incontinence, rectal and bladder bleeding and pelvic fracture and there are no FDA approved treatments
to protect normal rectal and anal tissues from radiation-induced damage. Radiation exposure leads to free
radical-mediated oxidative damage to normal tissues leading to fibrosis. Cancer cells have increased metabolic
production of reactive oxygen species (ROS), relative to normal cells, which have been shown to drive cancer
progression. Thus, suppressing radiation-induced ROS would act as both a radioprotector in normal tissues
while inhibiting pro-survival and progression pathways in cancer cells. BMX-001 is a small molecule antioxidant,
which scavenges ROS. Preliminary data demonstrate that BMX-001 protects rectal tissues from radiation-
induced damage, while enhancing colorectal cancer killing. The overall hypothesis of this proposal is that BMX-
001 will protect normal tissues from radiation-induced damage, while not protecting the cancer cells in patients
undergoing radiation therapy of rectal and anal cancers. Specific Aim 1 will determine the mechanism(s) by
which BMX-001 protects from radiation-induced epithelial dysfunction and how BMX-001 prevents blood chemo-
radiation toxicity. It will be determined whether BMX-001 prevents hematological chemoradiation toxicity through
the NRF2/MnSOD signaling and potential biomarkers of oxidative stress and GI damage will be identified in a
chronic in vivo model of radiation-induced damage. Specific Aim 2 will determine the safety and efficacy in
patients through Phase II clinical trials as a radioprotector of rectal cancers. A randomized phase II clinical trial
will determine whether BMX-001 is an efficacious radioprotector of normal tissues in rectal cancer patients
undergoing total neoadjuvant chemoradiation therapy followed by surgery. Specific Aim 3 will identify potential
biomarkers that can be used to demonstrate radiation damage and radioprotector efficacy of BMX-001 in human
clinical specimens obtained from the Phase II trial. Surgically resected tumor and adjacent normal rectal tissues
from BMX-001 or placebo controlled patients after chemoradiation will be evaluated for inflammation, normal
tissue damage, fibrosis and oxidative stress. In addition, oxidative stress markers will be evaluated in blood and
urine samples. The completion of the studies will provide an in depth mechanistic understanding of the
mechanisms by which BMX-001 inhibits normal tissue injury and whether BMX-001 can be used in rectal cancer
patients as an effective radioprotector and could be universally adapted for treatment of other cancers receiving
pelvic irradiation.

Public health relevance
PROJECT NARRATIVE Patients receiving radiotherapy for rectal cancers often suffer from debilitating side-effects due to radiation damage to tissues surrounding the tumor. Currently, there are no radioprotectors approved to be used with rectal cancer radiotherapy. An antioxidant drug, BMX-001, shows promise as an effective, clinical, radioprotector because the drug protects healthy tissues from radiation damage while, simultaneously, inhibiting growth of colorectal cancers.